Health Promotion and Disease Prevention Research Centers

Project Summary
The Prevention Research Center on Nutrition and Physical Activity at the Harvard Chan School of Public
Health has a mission to use community-based participatory research methods to engage with our partners
working in public health practice at the local, state, and national levels to promote translation and adoption of
obesity prevention interventions. Our proposed center and collaborative implementation research represent
opportunities to reduce future obesity prevalence and health disparities in Massachusetts, disseminate this
approach nationally, and use implementation science methods to study this knowledge translation gap. Our
Center Aims are to 1. Support the infrastructure and partnerships needed to establish an applied research and
translation agenda that will increase awareness of effective and cost-effective population health approaches to
improve nutrition and physical activity behaviors and establish policy, systems and environments that support
them. 2. Grow and develop strong partnerships with local communities, state and city health agencies, national
stakeholders and partners with resources and systems to disseminate knowledge and products to increase
translation of effective and cost-effective obesity prevention research into practice. 3. Implement activities to
support training of public health students and practitioners and partners and communication to create
enhanced local and national community capacity to translate effective and cost-effective strategies to prevent
obesity and reduce disparities into widespread, sustained practice. We will conduct an implementation
research project with Research Aims to: 1. Develop a learning collaborative implementation strategy with
community partners, with our state and local health agency partners, to initiate consideration of the
acceptability, feasibility, cost, and reach of intervention strategies to effectively reduce future obesity
prevalence, associated health outcomes, and disparities in obesity. 2. Utilize the learning collaborative
implementation strategy to build knowledge, skills, and self-efficacy of state and city health agency staff and
community partners to employ cost-effectiveness and health disparity concepts and methods in the selection of
interventions. 3. Gather local data with partners to create intervention blueprints and locally- tailored
microsimulation models to estimate cost-effectiveness and health disparity metrics for the selected obesity
interventions over 10 years (2019-2029). 4. Use mixed methods to assess adoption of the selected
interventions and cost-effectiveness analysis. We will engage with community partners to develop, evaluate,
communicate and disseminate information regarding the cost-effectiveness of interventions, and build
community capacity of partners to develop and use cost-effectiveness and health equity metrics in decision
making. We will produce strategic plans to guide local decision-making and adoption of strategies to advance
obesity prevention research and the translation of cost-effective public health strategies that improve
population health and reduce health disparities.

Public health relevance
Project narrative The proposed project will enable the Prevention Research Center on Nutrition and Physical Activity at the Harvard T.H. Chan School of Public Health to engage with our partners working in public health practice at the local, state, and national levels to promote translation and adoption of obesity prevention interventions. Our center and research agenda will advance obesity prevention research and the translation of cost-effective public health strategies that improve population health and reduce health disparities.